Spatiomolecular Profiling of Human Cancer at Scale

Abstract: Spatiomolecular Profiling of Human Cancer at Scale
The molecular and cellular architecture of a tumor within its tissue environment dictates disease progression and
sensitivity to therapy. Therefore, technologies to image and measure the spatial organization of the molecules
and cells that form tumors are critical to basic and clinical cancer research. While tumors are routinely evaluated
in the clinic using histopathology techniques such as hematoxylin and eosin (H&E) staining, recent technological
advances have heralded a revolution in the spatiomolecular analysis of cancer. For example, the development
of methods for spatially resolved transcriptomics (ST) have enabled the sequencing of the transcriptome
associated with specific areas of tissue sections. The application of ST to cancer research holds the promise to
crack the rules governing the structure-function relationships in tumors, but several key challenges in technology
must first be overcome. Several ST technologies have emerged from academic labs over the past half a decade,
but they remain limited by their low throughput, small surface area, lack of compatibility with H&E staining, and
high costs and barriers to adoption. As a result, there is only one ST technology that has spread beyond its
institution of origin thanks to commercialization and ease of adoption. Furthermore, the limitations of existing ST
methods compound with the issues of standard freeze-sectioning techniques that are prone to section loss and
damage and are not compatible with the analysis of large samples, such as surgical resections or whole organs
from cancer patients. Therefore, these gaps in ST and histology technologies preclude detailed spatiomolecular
analyses for cancer research across many samples, small or large, from cohorts of cancer patients. To address
these challenges, we first built a large-format ST profiling platform, Array-seq, by repurposing off-the-shelf DNA
microarrays with custom probes into ST-compatible slides. In proof-of-principle experiments, our Array-seq
prototype outperformed a widespread commercial ST platform in all metrics tested, including resolution,
sensitivity, surface area, and cost. Second, we created a technique for large-format histological sectioning while
preserving RNA which, combined with Array-seq slides, enables the spatiomolecular analysis of whole human
organs or adult rodents. Here, we propose to develop our Array-seq prototype and histology methods to deliver
a scalable, easy-to-adopt, and multimodal ST platform which will enable the high-throughput and cost-effective
spatiomolecular analysis of tumors. In addition, we will assess the performance of our spatial technology by
applying it to human colorectal cancer, providing a demonstration of the broad applicability of Array-seq for the
spatiomolecular characterization of cancer at scale – from whole-organ, human tumors to large patient cohorts.
Thus, our technology is poised to contribute to the spatial omics revolution in cancer research by making possible
large-scale studies to characterize cancer progression and response to treatment, inform clinical decision-
making, or find new therapy avenues.

Public health relevance
Project Narrative: Spatiomolecular Profiling of Human Cancer at Scale The next frontier in the spatiomolecular analysis of cancer is to develop technologies that can characterize small or large samples across cohorts of patients. Here, by combining the two workhorses in gene expression from the beginning of the 21st century – standard DNA microarrays and next-generation sequencing – we will develop a large-format platform for spatial omics profiling and validate it using samples from colorectal cancer patients. These technological advances will contribute to cancer research by enabling spatiomolecular studies to characterize cancer progression and response to treatment, inform clinical decision-making, and find new therapy avenues.